Elucidating the structure function relationship between TPP1 and telomere length control through deep scanning mutagenesis

ABSTRACT
Telomeres are tandem TTAGGG nucleotide repeats that cap the linear ends of human chromosomes.
They protect genetic information from gradual sequence loss due to incomplete chromosome end
replication and processing by nucleases. The shelterin complex binds to telomeric DNA and regulates
the elongation of telomeres by the enzyme telomerase. TPP1, a central component of this complex,
recruits telomerase to telomere ends and is therefore required for telomere length maintenance.
However, TPP1 also limits excessive telomerase activity by bringing the shelterin protein POT1 to
telomeres. Mutations in TPP1 that result in telomere shortening cause the bone marrow failure
syndrome dyskeratosis congenita, while mutations that elongate telomeres have recently been shown
to cause cancer. The fact that mutations in the same protein can cause dramatically opposing effects
on telomere length and disease poses a central challenge to the clinical evaluation of TPP1 mutations.
There are currently over 650 variants of uncertain significance listed in CLINVAR whose effects on
telomere length are unknown. The central goal of our experiments is to deploy deep scanning
mutagenesis of TPP1 to comprehensively characterize TPP1 mutations and perform a detailed
structure-function analysis to identify mutations that drive telomere length changes. Moreover, we seek
to uncover the molecular mechanisms governing length-dependent extendibility by telomerase by
identifying and characterizing TPP1 separation-of-function mutations that alter TPP1 abundance at
telomeres without leading to telomere deprotection. Our experiments will test the hypothesis that TPP1
density defines telomerase-extendible or non-extendible telomeric states to establish the normal
telomere length setpoint in stem cells and disrupting TPP1 density can cause human disease.

Public health relevance
PROJECT SUMMARY/ABSTRACT Mutations in the protein TPP1 that alter the length of human telomeres, the protective caps at the ends of human chromosomes, are linked to various diseases. TPP1 mutations that drive telomere shortening can lead to bone marrow failure, while those that cause telomere elongation are associated with cancer. This project aims to use deep scanning mutagenesis to comprehensively annotate patient mutations of uncertain significance, assess their impact on telomere length, and determine the mechanisms by which TPP1 establishes a length setpoint that is balanced in the healthy state.